IGF::OT::IGF DEVELOPMENT AND EVALUATION OF THE HEPAPLATE IPS: A HIGH THROUGHPUT ORGAN ON A CHIP IPS HEPATOTOXICTY SCREENING PLATFORM

This is an SBIR Phase I contract focused on improving the testing of hepatoxicity through the development of the organoplate.